NEPHROLOGY PATIENT REGISTRY

This project will establish a patient registry for the Renal Division. The intent of the investigators is to provide access to a computerized registry for hypothesis generating questions.